Investigating alterations in gustatory neuron innervation and function over the course of chemotherapy treatment

Abstract
Chemotherapy treatment frequently results in taste alterations that significantly impact patients' quality of life
and recovery. While transient loss of taste receptor cells (TRCs) has been observed in mice after
chemotherapy, this does not fully explain the prolonged taste disruptions reported by human patients. My
preliminary data indicates that gustatory fiber innervation in taste buds is reduced shortly after chemotherapy,
but the recovery of these connections and their effects on taste response remain unclear. This study aims to
investigate the timeline of gustatory fiber recovery after cyclophosphamide (CYP) treatment and assess the
strength and specificity changes in taste signaling. To determine the time course of gustatory fiber
reinnervation within taste buds after CYP treatment, I will use immunohistochemistry and intravital imaging to
monitor the recovery of gustatory fibers and taste synapses over 20+ days post-treatment. To assess the
degree to which cyclophosphamide alters the strength and specificity of taste signaling in mice, I will use
whole-nerve recording and in-vivo calcium imaging. This proposal is designed to unravel the recovery process
of gustatory fiber innervation after chemotherapy and explore strength and specificity changes in taste
signaling. In addition, activities planned for this proposal will strengthen my career development and training to
achieve my goal of becoming a leader in investigating neuro-immune interactions.

Public health relevance
Narrative: The sense of taste plays a vital role in our survival, enabling us to discern nutrients and toxins in our surroundings. Chemotherapy-induced taste dysfunction can lead to malnutrition and a reduced quality of life, underscoring the urgency of comprehending its causes and finding effective remedies for these adverse effects. This proposal aims to investigate the impact of a common chemotherapeutic, cyclophosphamide, on gustatory neurons to shed light on the underlying mechanisms of chemotherapy-induced taste dysfunction.